Novel Targeted Anticancer Agents from Marine Cyanobacteria

PROJECT SUMMARY
Cyanobacteria are among the most ancient organisms on Earth and have evolved chemical weapons for
defensive purposes, which we are exploiting for anticancer drug discovery. Our past research has exemplified
that marine cyanobacteria produce compounds with exceptionally potent activity and/or possess novel
mechanisms of action or act on new binding sites, including various tubulin-targeting agents. Dolastatin 10 had
the greatest clinical impact so far, leading to several FDA-approved antibody-drug conjugates (ADCs). The
clinical success of these ADCs with a dolastatin 10-based cytotoxic payload as well as success of other natural
products drugs acting on different pharmacological sites of tubulin suggest that targeting different sites may lead
to different pharmacological consequences and new drug classes. Our discovery of gatorbulin is a new prime
example for such natural product because it acts on a novel tubulin binding site. We will build on previous
discoveries and gradually shift towards rational optimization and preclinical studies, while maintaining a strong
pipeline based on new sourcing strategies, coupled with an augmented innovative screening platform predictive
of clinical activity. We apply a multidimensional screening platform focused on overcoming drug resistance in
solid tumors and hematologic malignancies, using innovative primary and secondary assays. We also integrate
a synthetic chemistry component into our cancer research program in order to perform rigorous biological
studies, to help solve the supply problem, and to improve on the activities of our natural products prioritized for
further developmental studies. Specifically, we will carry out field collections of marine cyanobacteria, targeting
underexplored species, and also explore a unique culture collection. We will prepare libraries, perform
dereplication, subject the samples to a set of phenotypic primary assays and designed secondary assays to
prioritize the potentially most impactful samples. Prioritized samples will be subjected to bioassay-guided
isolation of the active compounds. Structures will be determined using NMR and mass spectrometry. Several
scaffolds have already been prioritized based on novelty, targets and activity. We will design improved analogues
and assess their activity and selectivity profiles. One new pharmacologically-active compound class will be
advanced to in vitro and in vivo preclinical pharmacology.

Public health relevance
PROJECT NARRATIVE Marine cyanobacteria produce selective anticancer agents with specific molecular targets. This research will lead to the discovery and development of new compounds that could become new drug leads for the treatment of drug-resistant cancers.